DYNAMICS OF ENDOGENOUS GONADOTROPIN SECRETION IN RENAL FAILURE

We will characterize in detail abnormalities in the pulsatile mode of LH, FSH, and prolactin secretion and clearance in men with chronic renal failure using computer-assisted pulse analysis and deconvolution methods. These studies are anticipated to clarify the pathophysiology of hypogonadism in chronic renal disease.